The mechanisms and functions of short-term synaptic plasticity

Project Summary/Abstract
Synaptic plasticity, or the ability of neuronal connections to change over time, is essential to the brain’s ability
to store and process information. Enduring forms of plasticity such as long-term potentiation and depression
contribute to nervous system development, homeostatic tuning, and are thought to underlie learning and
memory. In addition, several forms of short-term plasticity modulate synaptic efficacy continuously on rapid
times scales ranging from milliseconds to minutes. Our understanding of how these rapid forms of plasticity
contribute to the function of the nervous system remains largely theoretical. Identifying the molecular
mechanisms for short-term plasticity will enable in vivo manipulations that can remedy this knowledge gap. We
recently linked two forms of short-term plasticity to Synaptotagmins (SYTs), a family of molecules that act as
crucial regulators of neuronal signaling by conferring Ca2+ sensitivity to the process of synaptic transmission.
The high-affinity Ca2+ sensor SYT7 is required for a prominent form of plasticity called facilitation. A closely-
related isoform, SYT3, mediates Ca2+-dependent recovery from depression. SYT3 and SYT7 appear to be
activated by different patterns of activity, and could thus mediate the majority of activity-dependent plasticity on
sub-second time scales. Revealing how these two SYT isoforms perform their functions will provide new
insights into the machinery that tightly regulates neurotransmitter release. In this proposal we will use genetic
manipulation of both SYTs to answer unsolved questions about the synaptic biophysics of short-term plasticity
and its impact on cognitive function. In Aim 1 we will use SYT3, SYT7, and double knockout mice to determine
the extent to which these two synaptotagmins determine the properties of short-term plasticity in the
cerebellum and hippocampus. In Aim 2 we will explore the molecular interactions that support short-term
plasticity using biophysical modeling and activity-dependent synaptic ultrastructure. Finally, in Aim 3 we will
use behavioral screening of knockout mice to screen for cognitive deficits that result from altered STP. Our
work will help to define the molecular interactions that support the most common forms of short-term plasticity,
and lay the foundation to study the contribution of short-term plasticity deficits in neurological disorders.

Public health relevance
Project Narrative Synaptic transmission in continuously modulated by short-term plasticity, a ubiquitous property of nerve terminals that rapidly changes the functions of neural circuits without physically restructuring connections. Altered short-term plasticity is implicated in multiple neurological disorders, but this link has been difficult to establish due to a lack of identified molecular mechanisms for plasticity. Building on our recent discovery of two key mechanisms for short-term plasticity, we will use knockout mice to define the molecular interactions and functional consequences of short-term plasticity.